Proteinase Inhibitors and Crystallin Fragments in Cataract

DESCRIPTION (provided by applicant): Age-related (senile) cataract is principally a crystallin protein aggregation and subsequent precipitation disease that occurs over the time frame of several years. During cataract development, the increased sizes of aggregated and cross-linked crystallin multimers become so large that they finally become water insoluble and cause lens opacity. Deamidation and truncations of crystallins are identified as the most abundant post-translational modifications (PTMs), and are believed to be the major causative factors in age-related cataract development. However, the mechanisms of cataract development by either deamidated- or truncated-crystallins are still unknown. Based on our extensive results, we have hypothesized that deamidated and truncation of crystallins synergistically cause cataract by producing aggregates that deposit on lens membranes and lead to fiber cells degeneration. The aggregation process is initiated by truncated crystallin fragments that form amyloid fibril-type of complexes alone and/or with fragments of deamidated crystallins, filensin and phakinin. In this process, βA3-protease-derived fragments of deamidated crystallins play a major role. We plan to test the above hypothesis by seeking answers to the following three questions: (1) What is molecular mechanism of cataractogenesis in αA-N101D transgenic mouse model? Our first ever available transgenic mouse model with αA-N101D transgene develops cortical cataract at about 7-month of age. Because several preceding phenotypic changes trigger cataract development at 7-months of age in transgenic mice relative to wild type mice, the mouse model will be used to elucidate the molecular mechanism of deamidated αAN101D-induced cataract development. (2) How is the active site of βA3 protease regulated and activated in vivo to proteolyze crystallins? We will determine how the active site βA3 protease is regulated intrinsically by its N terminal arm and extrinsically by αA- and αB-crystallins as inhibitors, and how βA3-protease preferentially proteolyzes deamidated and/or truncated crystallins relative to unmodified crystallins in vitro and in αA-N101D transgenic mice. (3) What is the molecular mechanism of aggregation of fragments of crystallins (derived via proteolysis by βA3-protease) and phakinin and filensin with a deamidated 4-kDa ?B fragment? It will be determined whether amyloidogenesis is the mechanism of aggregation among crystallin fragments (derived via proteolysis by βA3-protease), fragments of filensin and phakinin, and an in vivo existing deamidated 4-kDa ?B fragment. Because mainly human lenses will be used in these studies, the findings will be relevant to in vivo mechanism of age-related cataract development. The results will be of significant therapeutic value to delay the development and progression of age-related cataract.

Public health relevance
The overall goal of the proposal is to elucidate molecular mechanism of development of human age-related cataract due to the two most prevalent but synergistic in vivo post-translational modifications of crystallins: deamidation and truncation. Th proposed studies will provide answers to the central question about the mechanism of how deamidated and truncated crystallins aggregate and cause lens opacity. The findings would be used for therapeutic purpose to delay human age-related cataract.